SPORE for Translational Approaches to Brain Cancer

OVERALL: SUMMARY
The overall objective of the Northwestern Brain Tumor SPORE is to improve outcomes for brain tumor
patients. Of the various primary intracerebral neoplasms, glioblastoma (GBM) is the most common. GBM
patients that receive standard-of-care treatment have a median survival of 20 months, and 5-year survival is
extremely rare. Progress in developing better treatments for this lethal tumor has been disappointing. A major
contributor to this lack of therapeutic improvement is the delicate nature of the organ in which this cancer
occurs. There are significant limitations to how aggressively GBM patients can be treated surgically, and the
efficacy of systemically administered therapies are often compromised due to limited access to the brain. To
address the public health problem that is associated with glioblastoma, we have assembled a talented team of
investigators with extensive backgrounds in brain tumor research and therapy. All members of this team have
professional records indicating success in directing their own programs of research. Together, these faculty
initiated group interactions in order to bring a team science approach to bear upon the study and treatment of
GBM, and for which a multidisciplinary approach is needed for achieving meaningful progress.

Public health relevance
OVERALL: NARRATIVE The Northwestern Brain Tumor SPORE is for improving treatment outcomes for patients afflicted with highly malignant primary brain tumors, with particular emphasis on glioblastoma. This goal will be accomplished through the efforts of a talented group of investigators that will combine complementary expertise in a team science approach leading to meaningful progress in effectively treating tumors that currently have a dismal prognosis.